Role of RACK1 in RAG1 degradation and B cell development

PROJECT SUMMARY
B and T lymphocytes form the foundation of our adaptive immune system, which is based on specific
recognition of foreign molecules by structurally diverse surface antigen receptors. Structural diversity in these
receptors originates through site-specific rearrangement of the antigen receptor genes during lymphocyte
development. This rearrangement process, called V(D)J recombination, is initiated when the RAG1/2 proteins
introduce DNA double-strand breaks (DSBs) at antigen receptor gene segments, and is completed when the
DSBs are sensed and repaired by non-homologous end-joining. This process is subjected to many layers of
regulation, but an elementary means to constrain V(D)J recombination is to control the level of the RAG
proteins themselves. Work in this laboratory suggests that RAG1 levels are controlled by a RAG1 interacting
protein we identified called Vpr binding protein (VprBP; also called DCAF1), which exerts its control through
two different mechanisms: first, by promoting timely proteasome-dependent degradation of RAG1 through
VprBP’s association with a Cul4-DDB1 E3 ubiquitin ligase complex; and second, by regulating Rag
transcriptional induction under conditions that stimulate V(D)J recombination. The molecular details underlying
these mechanisms remain unclear. We have recently performed more detailed interactome studies, confirming
VprBP and DDB1 association with full-length RAG1 and identifying Receptor of Activated C Kinase 1 (RACK1)
as a promising co-factor in mediating RAG1 degradation based on previous work establishing it as an adaptor
for other modular cullin E3 ubiquitin ligases. These findings lead us to hypothesize that RACK1 regulates
RAG1 degradation and V(D)J recombination. To test this hypothesis, we will (i) establish the role of RACK1 in
regulating full-length RAG1 degradation in vitro and in cell models and, based on previous studies, its potential
for competitive inhibition by HSP90 and modulation by signaling pathways involved in activating Protein Kinase
C; and (ii) establish how loss of RACK1 in B cells affects B cell development, RAG1 protein levels, and V(D)J
recombination. Establishing the molecular basis for RACK1 interactions with full-length RAG1 and the Cul4-
DDB1 ubiquitin ligase complex, the role of RACK1 (and potentially HSP90 and receptor signaling pathways) in
regulating RAG1 degradation, and the consequence of losing RACK1 expression in B cells on B cell
development, RAG1 protein levels, and V(D)J recombination, would define a new physiological role for RACK1
(and HSP90) in V(D)J recombination, and provide new insights into sources for altered immune repertoire and
genomic instability caused by dysregulated RAG1 expression. This work would also extend the paradigm for
RACK1 as a multi-functional adaptor to E3 ubiquitin ligases and potentially reveal new avenues to
therapeutically regulate RACK1-dependent protein turnover.

Public health relevance
PROJECT NARRATIVE V(D)J recombination is a DNA rearrangement process that is responsible for generating a diverse population of B and T cells that together provide highly specific immunity to pathogenic microorganisms. The proposed research will investigate whether a protein called RACK1 regulates the cellular levels of the RAG1 protein required to initiate V(D)J recombination by promoting its degradation. This work will not only illuminate a novel role for RACK1 in regulating V(D)J recombination, but also reveal a new functional association with a distinct member of the cullin-RING family of E3 ubiquitin ligases in the ubiquitin-proteasome system.